Roles of Placental Mitochondria in the Vicious Cycle of Diabetes and Pregnancy

PROPOSAL ABSTRACT
Type II diabetes mellitus (T2D) with increasing prevalence represents a major burden for health and care system
and individuals. However, the root cause of T2D has not been understood completely. Recent human
epidemiological studies indicate that gestational diabetes mellitus (GDM) predisposes type 2 diabetes (T2D) and
other metabolic diseases in offspring, resulting in a vicious cycle of diabetes and pregnancy transgenerationally.
Therefore, developmental origins of health and diseases (DOHaD) may provide a new angle in the studies of
metabolic diseases including T2D. The dual roles of BNIP3 in mediating mitophagy and lipid metabolism suggest
that the deletion of BNIP3 in trophoblast cells is expected to impair placental mitochondrial function, lipid
catabolism, and thus, negatively affecting maternal metabolic adaptations to pregnancy and leading to the
development of GDM. We propose that BNIP3 may play a critical role in the process of placental development
and consequent programming of T2D in offspring. In this application, we hypothesize that BNIP3 mediated
placental mitophagy plays a critical role in the development of GDM and trophoblast specific knockout of Bnip3
in pregnant mice will cause maternal GDM and predispose T2D in offspring through placental programming.
Continuing our previous study, we will confirm the impaired placental mitophagy in GDM women which is
mediated by BNIP3 (Aim 1), then we will investigate the role of BNIP3 dependent mitophagy pathway in the
development of GDM in a mouse model with trophoblast specific knockout of Bnip3 (Aim 2). Using this unique
mouse GDM model, we will investigate the onset and progression of T2D in offspring (Aim 3). Taken together,
the proposed studies, for the first time, model the vicious cycle between maternal GDM and GDM predisposed
adult metabolic diseases by manipulating the placental mitophagy but not interfering with other maternal organs,
and thus, providing powerful platform in the mechanistic studies on GDM and T2D, helping develop novel means
for the prevention and treatment of these diseases, and breaking the vicious cycle of diabetes and pregnancy.

Public health relevance
PROJECT NARRATIVE Type 2 diabetes mellitus (T2D) with increasing prevalence presents a heavy socioeconomic burden, but the root cause of T2D remains unclear. We propose to understand the role of placenta mitochondria in predisposing T2D in offspring in women with gestational diabetes mellitus (GDM), using human tissues as well as a novel mouse GDM model. The expected findings will yield important insights into the study of placental mitochondrial dysfunction, and into potential therapeutic means for GDM and GDM predisposed T2D in offspring during maternal pregnancy, thus breaking the vicious cycle of diabetes and pregnancy.